Vaccine and Treatment Evaluation Unit at Saint Louis University - DMID 20-0034

Saint Louis University (SLU) seeks to expand its service to the Vaccine and Treatment Evaluation Unit (VTEU) network providing resources and expertise to help the network achieve its objectives of evaluating vaccines, preventive biologics, therapeutics and diagnostics for COVID-19.

Public health relevance
NARRATIVE: Saint Louis University proposes to continue and expand its service in the NIAID Vaccine and Treatment Evaluation Unit (VTEU) network. SLU aims to help the network achieve its objectives of evaluating vaccines, other preventive biologics, therapeutics, diagnostics, and devices to treat and prevent COVID-19.